CTDL Laboratory Core

The CTDL was designed to provide a centralized service to support investigators in the College of Dentistry who required biologic measures fortheir clinical, translational, and basic science projects. The core support services in the Phase III center operations include: (1) an array of measures of host responses in a range of biologic fluids (eg. serum, saliva, cervico-vaginal fluids, cell culture supernatants, tissue homogenates, etc.); (2) microbiological/virological assays for oral bacteria and bacteria from other mucosal sites, and viruses related to oral diseases. This includes cultivation, molecular analysis, and preparation of batches of organisms for in vitro studies; (3) genetics/genomics analysis which include preparation of DNA and RNA from various samples, analytic approaches for GWAS, SNP, miRNA, and epigenetic variations related to specific project needs; and (4) mineralized tissue analysis including both histomorphometric, microCT, and cellular studies of bone biology.

Public health relevance
While the CTDL is primarily designed to support UK investigators for a range of analytic services, specimens evaluated in this core could also be derived from populations derived from community-based partners. In either case, these outcomes will help create new knowledge of the biology of oral-systemic disease relationships to improve oral health in the population.